Exploiting KCNQ2 upstream open reading frames for therapeutic opportunity

PROJECT SUMMARY
Heterozygous loss-of-function (LOF) is a common genetic mechanism among many monogenic epilepsy genes
including KCNQ2, which encodes a brain voltage-gated potassium channel (Kv7.2). Pathogenic KCNQ2 variants
are associated with severe developmental and epileptic encephalopathies that lack targeted treatments. We
identified an upstream open reading frame (uORF) within the 5’-untranslated region (5’-UTR) of the KCNQ2
mRNA transcript that competes with the canonical reading frame for translation and attenuates Kv7.2 functional
expression in non-neuronal cells. Because suppressing uORF translation could be an effective strategy for
boosting KCNQ2 expression in the setting of heterozygous LOF, we seek to determine the physiological
relevance of the KCNQ2 uORF (Aim 1), and to target the uORF with antisense oligonucleotides (ASO) using a
structure-driven approach (Aim 2). Our approach to Aim 1 will involve genome editing of human induced
pluripotent stem cells (iPSC) to inactivate the uORF start codon and to compare uORF usage, Kv7.2 translation,
and electrophysiological properties of the channel in neurons differentiated from edited and non-edited iPSC
lines. For Aim 2, we will experimentally deduce the secondary structure of the KCNQ2 5’-UTR, then design a
series of ASOs targeting the least structured regions proximal to the uORF. We will then confirm binding of
candidate ASOs to the KCNQ2 mRNA transcript and determine if an ASO strategy will boost Kv7.2 translation
and function. These studies will clarify the physiological relevance of the uORF and identify a potential
therapeutic strategy to correct heterozygous LOF in this epilepsy gene.

Public health relevance
PROJECT NARRATIVE Genetic defects in the gene KCNQ2 can result in severe epilepsy affecting infants and children, but there are currently no specific therapies that target this gene. In this proposal, we are focusing on a specific element in the gene called an upstream open reading frame (uORF) that we discovered impairs optimal KCNQ2 translation into protein. Our work will determine if removing or blocking this uORF, possibly with a new class of drugs called antisense oligonucleotides, can boost levels of KCNQ2 protein in neurons as a potential strategy to overcome the predisposition to seizures and epilepsy caused by genetic defects in this gene.